HPV Serology Methods Study

Immune monitoring is an important objective for the new one-dose trial (1DT) we plan to initiate later this year. Performance of assays designed to monitor immune response to single-dose vaccination are not fully understood (because levels seen after 1 dose are 4-5x lower than those observed after 2-3 doses). Also, given that the 1DT will include both the bivalent and the nonavalent vaccines, there is an interest in expanding testing beyond the two HPV types we have evaluated in the past. Evaluation of multiplex assays that incorporate all 9 HPV types included in the nonavalent vaccine is therefore of interest.

Public health relevance
Public Health Relevance: Determining the response on the immune system of 1 dose, 2 doses vs. 3 doses of the licensed HPV vaccines will help determine whether it is medically effective and equivalent protection to decrease the # of doses provided per person. This would substantially increase the ability to vaccinate larger areas of the medically underserved populations around the US and the world in a cost and time effective manner.